Core B: B-HEARD Core

ACAD U19 Outreach and Education Core Abstract
To address the limited participation among Asian Americans and Canadians (ASACs) in Alzheimer’s disaesae
and related dementias (ADRD) research, the goal of the ACAD U19 Outreach and Education Core (B), Brain
Health Education and Risk of Dementia (B-HEARD), is to provide the education/outreach tools to engage
and recruit older ASACs in ADRD research, which is relevant to both proposed ACAD projects (i.e.,
education/outreach on what research is, especially ADRD genetics, lifestyles, and biomarkers research). We
will use community-based participatory research (CBPR) methods, and leverage/expand on the multi-lingual
outreach resources in Multiple Principal Investigator (MPI) Park’s NIA-funded Collaborative Approach for Asian
Americans and Pacific Islanders Research and Education (CARE) research recruitment registry. The proposed
aims will be conducted in five written languages (English, Korean, Simplified Chinese, Traditional Chinese,
Vietnamese) and five spoken languages (Cantonese, English, Korean, Mandarin, and Vietnamese): Aim 1. To
develop and promote the use of culturally and linguistically appropriate educational resources for
recruitment and retention in ADRD research including ACAD; Aim 2. To monitor ACAD
recruitment/outreach, develop metrics of success, and provide support for recruitment success; and
Aim 3. To develop and provide training to ADRD researchers on the best practices of CBPR and
communication approaches with older Chinese-, Korean-, and Vietnamese Americans and Canadians
about ADRD research participation. B-HEARD aligns with two major goals of the NIA’s strategic directions
for research which are to 1) Support the infrastructure and resources needed to promote high-quality research;
and 2) Disseminate information to the public; scientific and medical communities; stakeholder advocacy,
community, and older adult-support organizations; the media; and policymakers about research and
interventions. The proposed resources may be added to the NIA ADORE, which may assist other ADRD
researchers in recruitment and retention of ASACs, thereby, helping to improve diversity and inclusion of
underrepresented populations (i.e., ASACs) in ADRD research.